UM Calabresi Clinical Oncology Research Career Development Award

PROJECT SUMMARY
The University of Miami (UM) Calabresi Clinical Oncology Research Career Development program is designed
to launch the careers of clinical researchers committed to pursuing patient-oriented cancer research.
Identifying such individuals and facilitating their career development will ensure that a new generation of
clinician scholars can effectively translate scientific discovery to clinical research opportunities that improve the
delivery of cancer care and accordingly, patient outcomes. As of recent, the University of Miami Sylvester
Comprehensive Cancer Center has experienced substantial growth in its basic, translational and population
science programs and has necessary infrastructure to support a successful K12 Program. UM has an
outstanding cadre of Translational and Clinical Mentors, as well as, a large pool of strong and remarkably
diverse potential K12 scholars to launch the proposed career development program.
those
radiation,
faculty
and
University's
practicums
such
of
Scholars will include
who recently completed postgraduate training in a subspecialty oncology program (pediatric, urologic,
surgical, hematology, head and neck, gynecologic) and those who have recently assumed their first
appointment. Scholars will choose a mentoring dyad composed of a Translational and a Clinical Mentor,
will have the option of obtaining a Masters in Clinical and Translational Investigation, supported by our
Clinical Translational Science Institute. Scholars will choose from a wide range of courses and
designed to assist them in translating research discoveries into clinical practice. They will then use
knowledge to design, implement and manage a clinical cancer therapy trial , which draws from the findings
ongoing translational and population-based research initiatives led by K12 mentors.The UM K12 Program
will fulfill the major objectives of the Calabresi Award. It will provide, for a two-year period, dedicated time,
optimal mentorship, formal education, and practical experience in developing novel, patient centric clinical trials
to a diverse group of talented, and highly-motivated clinical Scholars. The Program will evaluate short and
long-term outcomes of scholars' professional trajectory and use corresponding data to adjust the program to
appropriately meet the dynamic and rapidly changing landscape of clinical oncology research. An important
feature of the UM K12 Program is its geographic location in South Florida, which is characterized by
unparalleled multiculturalism. Such diversity provides a unique opportunity to develop trials responsive to the
unique needs of racial/ethnic minorities, recent immigrants, and other population sub-groups, who contribute to
cancer disparity.

Public health relevance
PROJECT NARRATIVE The University of Miami (UM) Calabresi Clinical Oncology Research Career Development Award program will support the career development of scholars and junior faculty committed to patient oriented clinical research. Program coursework capitalizes on the unique strengths of UM's faculty and South Florida's increasing multiculturalism.